Replication Study of Off-Target Assays for Guide RNAs in CRISPR-Based Therapeutics

PROJECT SUMMARY/ABSTRACT.
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-RM-
24-009. In vivo gene editing still faces substantial challenges, especially when it comes to safety, efficacy, and
delivery. In particular, the variability in off-target effects of CRISPR-based therapeutics poses a significant
challenge for their clinical application. By systematically comparing inter-lab studies, this proposal will provide
critical insights into the reproducibility and reliability of off-target assays. The findings could inform best
practices for assay and reagent selection, ultimately enhancing the safety and efficacy of CRISPR-based
therapies. Using contract research organizations (CROs), this study introduces a novel approach to comparing
off-target assays with a clinically relevant non-viral formulation. This innovative comparison will provide a
deeper understanding of the factors influencing assay outcomes, paving the way for more reliable and
standardized methodologies in preclinical research. In the first aim, we will compare off-target nomination
assays using W53* guide RNAs for our lead Trailblazer formulation in our U19 SCGE parent award. The CRO
will purchase or acquire reagents from the labs within the parent award and perform genome-wide off-target
nomination assays at their facility. The results from the CRO will be compared against completed CasOFFinder
and CHANGE-Seq-BE nomination assays already completed. We will compare the sensitivity, specificity, and
reproducibility of the assays. In the second aim, we will compare short-read sequencing around nominated off-
target sites in W53* patient-derived retinal cells. The CRO will deliver the editor to a human biological model of
the target cell type, retinal pigment epithelial cell differentiated from induced pluripotent stem cells (iPSC-RPE).
The CRO purchase or acquire reagents from the labs within the parent award and perform sequencing at their
facility. Again, we will compare the sensitivity, specificity, and reproducibility of the assays. This replication
study will provide critical data on the variability of off-target assays, informing best practices for CRISPR-based
research. The results will enhance the reliability and reproducibility of off-target assays, supporting the
development of safe and effective CRISPR-based therapeutics.

Public health relevance
PROJECT NARRATIVE – OVERALL Genome editors make targeted changes in the genome and hold great promise in translational research but moving them into investigational new drugs has been slow and challenging. Because off-target analysis is essential to perform prior to clinical studies, this supplement to the CRISPR Vision Program seeks to replicate off-target assays to aid in the development of novel human genome editing therapeutic platforms. The proposed supplemental work would increase the rigor and reproducibility of off-target assays, ultimately informing the safety of candidate gene correction treatments.